Establishing a novel 13C-labeled metabolite library for the study of dental caries

PROJECT SUMMARY
Bacteria contain a vast diversity of metabolites due to rich accessory genomes 100 times greater than that
found in humans. Most of these metabolites are unknown metabolites and are often excluded from current
metabolite studies that use standard metabolomics references limited to common human, drug or industrial
chemicals, providing an incomplete perspective in these investigations. There is currently no oral bacterial
metabolite reference library available for the study of dental disease by metabolomics. The overarching goal of
this research plan is to establish a novel 13C-labeled oral bacterial metabolite reference library with known oral
bacterial strains and to propose an unprecedented integrated workflow approach combining the 13C-labeled
oral bacterial metabolite library with clinical samples to select targeted unknown metabolites to be analyzed for
differential LC-MS, transcriptomics and genetic modification leading to full characterization of unknown oral
metabolites related to dental caries or health. In Aim 1, a 13C-labeled oral bacterial metabolite reference library
for Streptococcus mutans and Streptococuss gordonii will be created using SWATH LC-MS, with dual peaks
identified and curated to improve rigor and reproducibility in oral metabolomics studies. Under Aim 2, the
newly generated oral bacterial metabolite reference library will be evaluated for feasibility and optimized for its
application in the study of clinical saliva and plaque samples for the study of caries versus health. The goal of
Aim 3 will be to establish the unprecedented workflow using the 13C-labeled oral bacterial metabolite library
combined differential metabolomics, transcriptomics analysis, and genetic modification leading to isolation,
purification and full characterization of previously unknown bacterial metabolites relevant to caries versus
health. Creation of a 13C-labeled oral metabolite reference library is crucial for the generation of quality oral
metabolomics analysis by allowing for differentiation and removal of noise or artifacts, quantification of labeled
metabolites, preliminary identification of unknown compounds, normalization across multiple
laboratories/equipment, corrections for ion suppression and, by our novel approach, will allow unknown
metabolites to be linked back to specific oral bacteria for full structural elucidation. Most importantly, this
approach will allow the inclusion of oral bacterial metabolites previously missed, overlooked, or excluded in
other studies. This research will resolve many of the issues of quality metabolomics in oral studies, while
limiting the unknowns to target for isolation, purification and characterization to manageable numbers. Solving
these challenges in oral bacterial metabolomics will greatly advance the field of oral metabolomics
investigations, leading to novel natural products discovery that can be used as treatment or prevention of oral
(e.g., childhood dental caries) or other human disease.

Public health relevance
PROJECT NARRATIVE Currently, there is no oral bacterial metabolite reference library available to allow for high-quality in oral metabolomics studies, limiting reported metabolite data to common human or chemical metabolites while excluding most bacterial metabolites. This research will resolve many of the quality issues in oral metabolomics research, while limiting the number of unknown bacterial metabolites for isolation, purification, and characterization to manageable numbers using a novel systems biology approach. Solving these challenges in oral metabolomics will greatly advance the field, including novel natural products discovery that could be used as treatment or prevention of oral disease (e.g., dental caries) or other human disease.